Influence of the Host Microbiome on the Mechanism of FVIII Immunogenicity: Project 3

Project
3
Abstract
The development of an immune response to factor VIII (FVIII) in ~30% of persons with severe hemophilia
A (HA) represents the most important complication of treating this condition. The formation of anti-FVIII
antibodies (inhibitors) significantly compromises the clinical care of these patients, and their subsequent
management is less predictable, practically challenging and often extraordinarily costly. The
pathogenesis of FVIII inhibitors is recognized to be complex and multifactorial. Most patients that develop
this complication do so during the first 25 exposures to FVIII replacement therapy, within the first 2-3
years of life. While there are clear genetic predisposing factors for inhibitor development, such as the
mutant F8 genotype, a range of acquired influences also contribute to inhibitor risk. In this project, we will
investigate the role of an environmental factor that, to date, has not been studied in this context – the gut
microbiome. There is substantive evidence that the gut microbiome plays an important role in the
development and regulation of the systemic immune system, and that there are clear associations
between the gut microbiota and certain forms of immunopathology. In addition, the microbiome
undergoes significant changes during the first two years of life, the time when initial FVIII treatment occurs
in boys with severe HA, and the period of maximum risk for FVIII inhibitor generation. In Project 3 of this
research program we will address three objectives related to microbiome influences on FVIII inhibitor
formation. We will first evaluate the influence of changes to the gut microbiome-related metabolite
environment on the immunogenicity of FVIII. In particular, we will determine whether the products of
tryptophan metabolism and levels of the short chain fatty acids, acetate, butyrate and propionate
influence innate and adaptive immune responses to intravenously administered FVIII. In the second
series of experiments, we will conduct studies utilizing our recently developed germ-free HA mouse
model. In these studies, we will begin with an assessment of the likelihood for FVIII inhibitor development
in the absence of gut microbes, and will then progress to studies in which we selectively repopulate the
gut microbiota through various strategies including fecal transplantation from HA mice with and without
FVIII inhibitors. Lastly, we will conduct studies to evaluate the role of the gut microbiome in regulating the
immune response to orally delivered FVIII. These experiments will assess the interaction of FVIII with
various antigen presenting cell populations and will determine the cytokine and T cell context of the FVIII
immune response in the gut associated lymphoid tissue, liver and spleen. Overall, we propose that this
program of research will provide important new knowledge concerning the role of the gut microbiome and
FVIII immunogenicity. This new information is very likely to have significant biological and potential
translational implications.